Digital treatments for opioids and other substance use disorders (DIGITS) in primary care: Observational Analysis of Adaptions to the Intervention

PROJECT SUMMARY
The proposed study addresses a critical knowledge gap: How to best implement digital treatments for
opioids and other substance use disorders (SUDs) in primary care (PC). reSET and reSET-O are
smartphone-based, FDA-cleared versions of the Therapeutic Educational System, which is a computerized
cognitive-behavioral treatment for SUDs. We will study their implementation into PC to potentially improve care
for people with SUDs, and as a model for how to sustainably implement digital treatments into real-world
healthcare. Digital treatments could extend the reach of SUD therapy to more people and could address a
significant barrier to buprenorphine prescribing in PC: the lack of access to psychosocial treatment. Delivery
system leaders in Kaiser Permanente Washington are our collaborators for studying strategies for
implementing reSET and reSET-O in Washington State to address prior implementation challenges
documented in the literature. After piloting in 2 clinics, we will randomize up to 23 PC clinics in a 2x2 factorial
design to four approaches: (1) “standard implementation,” which is an evidence-based implementation strategy
previously used by our delivery system partners; (2) “standard implementation with external facilitation,” a
clinician-facing implementation strategy; (3) “standard implementation with patient coach,” a patient-facing
implementation strategy using medical assistants to support patient adoption and engagement; and (4)
“standard implementation with both.” These implementation strategies have some evidence in PC, but their
impact on real-world implementation of a digital treatment has not been evaluated. Specific Aims are to (1)
Estimate the effect of clinician-facing (external facilitation) and patient-facing (patient coach) implementation
strategies in increasing the reach and fidelity of a digital SUD treatment in PC clinics, and (2) compare the
population-level cost-effectiveness of each implementation strategy in increasing reach, fidelity, and
abstinence by patients. This administrative supplement will allow our study to recover from COVID-related
delays and (3) estimate the impact of: training non-social work clinicians to prescribe reSET and reSET-O,
allowing prescriptions without requiring follow-up visits, and centralizing the administrative tasks of prescribing.
IMPACT: Researchers and health systems do not know how to reach large numbers of patients with OUDs
and other SUDs. Digital treatments are promising, but health systems lack evidence to guide implementation of
digital therapies. This study will estimate and compare the effectiveness of clinician-facing and patient-facing
implementation strategies, providing health system leaders with data on how to best implement digital
treatments.

Public health relevance
NARRATIVE No change from parent award